Targeting iron metabolism in pancreatic adenocarcinoma to overcome KRAS inhibitor therapeutic resistance

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDAC) is the third most common cause of cancer-related death in the US
with dismal five-year survival rates of 13%. KRAS is the dominant oncogene in PDAC and is mutated in ~90%
of tumors. While considered undruggable for over 40 years, recent advances have led to the development of
mutant allele-specific KRAS and pan-RAS inhibitors (KRASi) that demonstrate activity in PDAC patients in early
clinical trials. However, resistance is a near-universal feature of targeted therapies. Therefore, there is an urgent
need to understand how to effectively implement KRAS inhibition to prevent resistance and maximally benefit
patients. Through this research plan, we will define the iron and autophagy-dependent mechanisms of KRASi
resistance and identify novel KRASi combinatorial approaches targeting iron metabolism to overcome
resistance. The rationale for this approach is based on our prior work defining PDAC dependency on a pathway
that links iron metabolism and autophagy called ‘ferritinophagy’, whereby a selective autophagy receptor,
NCOA4, targets ferritin, the cellular iron storage complex, to the lysosome for ferritin degradation and release of
iron to the cytosol for utilization. Furthermore, our preliminary data suggests that PDAC upregulate
ferritinophagy-mediated iron supply to sustain mitochondrial metabolism and proliferation after acute KRASi and
in long-term epithelial-to-mesenchymal transition associated KRASi resistance. However, iron addiction is a
double-edged sword as iron increases susceptibility to ferroptosis, an iron-dependent form of cell death.
Therefore, a key approach in targeting KRASi resistance may be to disrupt iron metabolism by ‘starving’ tumor
cells of iron or, conversely, by promoting iron-dependent ferroptosis. The overarching hypothesis of this proposal
is that disrupting iron homeostasis in PDAC by either iron depletion (ferritinophagy inhibition) or iron overload
(ferroptosis induction) in combination with KRAS inhibition represents an anti-PDAC therapeutic strategy. We
will evaluate this hypothesis in three aims: 1) to define dysregulated ferritinophagy and iron metabolism as
mechanisms of acute adaptive resistance in PDAC to KRASi, 2) to target epithelial-to-mesenchymal transition
and iron metabolism as non-genetic mechanisms of long-term acquired resistance to KRASi in PDAC, and 3) to
target KRASi resistance by ferroptosis induction. To accomplish our aims, we will leverage our scientific expertise
in autophagy, iron metabolism and pancreatic cancer and our technical expertise in quantitative proteomics, cell
biology, and patient-derived and mouse models of PDAC. Furthermore, we have assembled a collaborative team
with complementary expertise in PDAC genetics and translational models, PDAC clinical trial correlative science,
the chemical biology of cellular iron sensing, ferroptosis, and in novel chemistry for targeting cancer iron
metabolism. Deciphering the relevant iron acquisition pathways and iron-dependent functional requirements that
can mediate KRAS inhibitor resistance in PDAC may identify new therapeutic targets and combination therapies,
which is critical for patients with PDAC given the lack of effective treatment options for this devastating disease.

Public health relevance
PROJECT NARRATIVE Pancreatic adenocarcinoma (PDAC) is a highly lethal cancer that is characterized by KRAS mutations in over ~90% of patients. Recent advances have led to the development of KRAS inhibitors that demonstrate activity in PDAC patients in early clinical trials; however, acquired resistance to KRAS inhibitors will limit the long-term clinical benefit for patients. In this study, we will define the role of dysregulated iron metabolism as a resistance mechanism to KRAS inhibition and develop useful therapeutic strategies targeting iron metabolism to circumvent or prevent KRAS inhibitor resistance.